ORAL RETROVIR IN TREATMENT OF CHILDREN WITH SYMPTOMATIC HIV INFECTION

This study will evaluate the safety and tolerance as well as the clinical, immunologic and virologic effects of oral Retrovir therapy administered for 24 weeks to symptomatic HIV-infected children 3 months to 12 years of age.